Efficacy of a Virtual Reality Neuroscience-based Therapy for Chronic Low Back Pain

PROJECT SUMMARY / ABSTRACT
CognifiSense has developed a unique, patented VR therapy for chronic pain, called Virtual Reality Neuroscience-
based Therapy (VRNT). VRNT is specifically designed to create substantial and lasting pain reduction by
targeting the centralized drivers of pain chronification and amplification. Following our highly successful Phase I
study, the goal of this Phase II project is to make the VRNT system market-ready and demonstrate its efficacy
in a pivotal randomized controlled trial (RCT). Phase II data will subsequently be used in an FDA submission.
Chronic pain is a serious medical condition impacting an estimated 1 in 5 Americans. Chronic lower back pain
(cLBP) is the most common type of chronic pain, affecting 27 million Americans. Chronic pain is a complex
biopsychosocial condition with a significant centralized (central nervous system) component, which must be
addressed to yield clinically meaningful, long-lasting reductions in pain. Standard treatments for cLBP yield small
to medium magnitude effect sizes, and many involve risk of significant side-effects and / or addiction.
Pharmacological treatments simply mask effects and do not address any underlying, centralized drivers of pain.
Devices seek to address peripheral or ascending pain signals. The leading psychological therapies aim to
improve primarily behavioral and emotional functioning rather than reduce pain intensity. Numerous clinical trials
have shown that the effects of these treatments on pain intensity are small, and long-term effects are even more
limited. Virtual reality (VR) pain therapies have shown significant promise, but most VR therapies focus on
digitizing traditional psychological therapies or therapies only effective for acute pain.
VRNT takes a unique approach. It uses patented technology that incorporates the latest pain neuroscience and
newer, more effective psychological therapies to provide experiential learning and novel skills training to correct
maladaptive neural processes. In our NIH-funded SBIR Phase I research, we established clinical proof of
concept for VRNT with a small-scale randomized clinical trial of people with cLBP. The trial demonstrated that
VRNT creates clinically meaningful post-treatment improvements in pain. Moreover, we generated brain imaging
data that provided preliminary evidence of neuroplastic changes in the brain that paralleled chronic pain
reduction from VRNT treatment. The current Phase II application will support research to make VRNT market-
ready and provide pivotal data on VRNT’s placebo-controlled effect magnitude and long-term efficacy.
The Specific Aims of this proposal are: 1) Port VRNT to a new VR hardware platform and make minor
modifications to improve usability and engagement. 2) Develop sham VR software using an accepted sham VR
design. 3) Demonstrate VRNT’s clinical efficacy and durability in people with cLBP in a sham-controlled RCT.

Public health relevance
PROJECT NARRATIVE CognifiSense has developed a unique, patented virtual reality therapy for chronic pain, called Virtual Reality Neuroscience-based Therapy (VRNT), which is specifically designed to create substantial and lasting pain reduction by targeting the centralized drivers of pain chronification and amplification. In a SBIR Phase I clinical proof of concept trial VRNT demonstrated clinically meaningful post-treatment improvements in pain, and brain imaging data provided preliminary evidence of neuroplastic changes in the brain to parallel chronic pain reduction. The goal of this Phase II project is to make the VRNT system market-ready and demonstrate its efficacy in a pivotal randomized controlled trial.